Characterization of Ras/Akt/CFIm25/APA signaling in Glioblastoma Development and Progression

PROJECT SUMMARY Glioblastoma multiforme (GBM; World Health Organization grade IV glioma) is the most common and most aggressive brain tumor. Despite aggressive treatment with surgery, radiation, and the alkylating agents like temozolomide (TMZ), GBM inevitably recurs, and the median survival of GBM patients is only 15 months [3]. It is well documented that disruption of receptor tyrosine kinase (RTK)/Ras and phosphoinositide 3-kinase (PI3K)/Akt signaling is a key driving event in GBM. However, accumulating evidence has emerged implicating the importance of alternative polyadenylation (APA) in GBM, which is manifested through downregulation of the APA regulator called Cleavage Factor I of 25 kDa (CFIm25). Over 50% of human genes have multiple polyadenylation sites in their 3'UTR and its shortening is observed in response to proliferation or transformation or tumorigenesis. The Cleavage Factor I 25kDa subunit (CFIm25) is a master regulator of 3'UTR APA, and reduce of CFIm25 expression was associated with worse survival in TCGA GBM patients. Our previous study demonstrated that reduction of CFIm25 enhanced cell proliferation through 3'UTRs shortening of several oncogenes, including Cyclin D1. In addition, we observed that shortened 3’UTRs in breast cancers are strongly associated with repression of tumor suppressors in trans via competing endogenous RNAs (ceRNAs) crosstalk. At the heart of this proposal, we are going to test the relationship between CFIm25 inactivation, Ras/Akt activation, and 3'UTR APA events in cell proliferation. We are also going to test the critical role of Ras/Akt/CFIm25/APA axis in GBM development and progression in vivo. We will be testing two Specific Aims: Specific Aim 1. What are the key 3'UTR APA genes in response to CFIm25 inactivation and/or Ras/Akt activation in cell proliferation? Specific Aim 2. What is a critical role of CFIm25 inactivation in cooperation with Ras/Akt activation to promote GBM?

Public health relevance
PROJECT NARRATIVE Recent observations demonstrate that as GBM progresses, cells shorten the 3'UTRs of select mRNA through a process called alternative polyadenylation (APA). This proposal aims to employ polyA click-seq technology to identify APA events specific for GBM and to characterize the critical role of Ras/Akt/CFIm25/APA axis in GBM development and progression. Successful completion of this research will generate potential biomarkers for GBM and will produce data for more detailed long-term studies leading to a better understanding of how APA is altered during tumorigenesis.